Inflammatory subtypes and multi-omic determinants of early life infection risk

PROJECT SUMMARY
Nicole Prince, PhD is a biochemist with expertise in applying molecular epidemiology analytic approaches to
understand complex diseases. Her overarching career goal is to become an independent researcher with a skill
set across multiple ‘omics to improve understanding of the biological determinants underlying respiratory
infection risk, one of the leading causes of mortality in children <5 years (YR) of age. The proposed research
plan leverages her background in biochemistry and analytical chemistry with new training in immunology,
respiratory medicine, and multi-omic methods, to enhance her ability to study the complex, heterogeneous
environment that underlies infection susceptibility during the first few years of life. Evidence suggests there are
genetic and epidemiological drivers of susceptibility across different subsets of children, but these cannot fully
explain the observed inter-individual variability in respiratory infection risk; and, the hypothesis of this proposal
is that subsets of children with distinct infection risk are best captured through the proteome, which
represents the composite inflammatory profile critical to infection response. This will be explored in a cohort of
children with existing proteomic and metabolomic data and extensive longitudinal follow-up through age 10 YR,
originally enrolled in the Vitamin D Antenatal Asthma Reduction Trial (VDAART). (Aim 1) Proteomic profiling
will be used as input to derive inflammatory subtypes (i.e.,“inflamma-types”) at age 1 YR using a discovery
and validation approach; then, a high risk inflamma-type for respiratory infections will be identified. (Aim 2)
Inflamma-types will be recapitulated at age 6 YR to investigate their stability across the spectrum of
respiratory maturation and immune development. Finally, (Aim 3) inflamma-types will be characterized
biochemically to identify key metabolites and key pathways through the metabolome and assess their
roles as mediators in subsequent disease development (i.e., asthma). This innovative research plan utilizes
novel methodologies and will represent the first study to derive proteomic-driven subtypes to understand
respiratory infection risk. An accompanying training plan is designed to provide Dr. Prince support in completing
these research aims successfully and facilitate her transition to independence. These findings will provide critical
preliminary data to submit subsequent R01 applications to externally validate inflamma-types and assess their
clinical utility. Dr. Prince has four career goals that build upon her existing reputation as a biochemist to (1)
gain foundational knowledge in immunology and respiratory medicine; (2) increase clinical
understanding of respiratory infections in early life; (3) strengthen her knowledge of multi-omics
interpretation; and (4) deepen her understanding of study design, mentoring, and research ethics. She
is supported by a mentoring team with diverse skill sets and successful mentoring careers which will complement
her training to guarantee the success of this proposal. The findings generated here will pave the way to improved
understanding of the ‘omic contributors to respiratory infection risk and subsequent diseases.

Public health relevance
PROJECT NARRATIVE Respiratory infections are a leading cause of morbidity and mortality in children <5 years of age, but there is a gap in understanding of the biological determinants of inter-individual variability in infection risk. This proposal applies an innovative approach to derive proteomic-driven subtypes (i.e., “inflamma-types) correlated to respiratory infection risk, then biochemically characterize these inflamma-types to identify key ‘omic features contributing to risk variability and the development of subsequent diseases in high risk individuals. These findings will pave the way towards targeted therapeutics and personalized medicine approaches, ultimately to improve quality of life for children suffering from recurrent respiratory infections in early life.